Consortium for Viral Systems Biology Administrative Core

Project Summary / Abstract
An eﬃcient administrative structure is essential to the design and implementation of the CViSB U19 Center.
The Admin Core will be focused on facilitating communication, collaboration, planning, data sharing, and
scientiﬁc and ﬁscal oversight of the component research projects of CViSB. Through the Admin Core we will
oversee all the goals of the Center and ensure their successful, cost-eﬀective, and timely completion. The
Admin Core will organize the ﬁrst Kick-Oﬀ Meeting and Annual Programmatic Meetings near Bethesda.
Together with a Modeling Core, we will also organize an annual Systems Biology workshop. The Admin Core
will coordinate, schedule, and implement monthly internal teleconferencing meetings among the Center sites,
and will assist the PIs of the Cores and Projects in the preparation of progress reports, internal compliance
ﬁlings, and manuscripts to support the overall goals of CViSB.
The Admin Core will be responsible for the following Speciﬁc Aims: (1) Create an administrative and
leadership structure of the CViSB. (2) Organize outreach activities for the broader scientiﬁc community. (3)
Provide an eﬀective and responsive line of communication between CViSB members and NIAID staﬀ. (4) Build
a supportive structure between all CViSB investigators. (5) Assist Core and Project PIs with administrative
aspects. (6) Communicate with other Centers to facilitate collaboration and coordination. (7) Organize annual
programmatic meeting of CViSB members and NIAID staﬀ. (8) Coordinate periodic evaluation of CViSB and
engage the Steering Committee. (9) Facilitate building an infrastructure for rapid and open source sharing of
data and research resources, as well as coordinate scientiﬁc publications.